The impact of the aging immune system on periodontal disease

Project Summary
This is an application for Dr. Daniel Clark for a Mentored Clinical Scientist Research Career Development Award
(K08). Dr. Clark has been training to establish himself as an investigator in basic science research of
osteoimmunology, and this award will provide Dr. Clark with the support and opportunities necessary to reach
his career goal of being an independent researcher. In pursuit of his career goal, the K08 award will allow Dr.
Clark to: (1) to become an expert in osteoimmunology; (2) develop an independent research program through
novel application of osteoimmunology to the investigation of periodontal disease; (3) create a productive and
impactful publication record; (4) enhance grant writing skills and create a record of successful utilization of past
and current awards. Towards his career goal, Dr. Clark has established a transdisciplinary team to provide their
expertise in research training and mentorship in career development. Primary mentor Dr. Ralph Marcucio (expert
in bone biology) and co-mentor Dr. Mary Nakamura (immunologist and expert in osteoimmunology) will provide
foundational training in osteoimmunology, and co-mentor Dr. Yvonne Kapila (leading dentist-scientist and
periodontal basic science researcher) will provide expertise and guidance for osteoimmunological applications
to periodontal disease research. In addition, collaborators Drs. Marina Sirota, Eben Alsberg, and Saul Villeda
will provide their expertise of bioinformatics, cell-based therapeutics, and aging biology respectively. Immune
system dysfunction increases with age and is associated with an increased prevalence and severity of
inflammatory conditions in elderly populations, including periodontal disease. The cellular and molecular process
regulating the inflammatory response that become perturbed by age are unknown. Dr. Clark's long term goal is
to identify cellular and molecular targets for immunomodulatory treatment of periodontal disease. The objective
of this proposal is to understand how a key cellular regulator of the innate inflammatory response, macrophages,
interacts with mesenchymal stem cells (MSCs) and Th17 cells, to regulate inflammation in bone and how these
processes become dysregulated with age. Dr. Clark will utilize primary cell lines from young and old mice and a
periodontal disease mouse model to investigate (1) the extent to which macrophages and MSCs interact through
triggering receptor expressed on myeloid cells-2 (TREM2) to downregulate inflammation; (2) the extent to which
an aged macrophage phenotype drives pathogenic Th17 cell expansion; (3) and demonstrate the effect of
immunomodulation with cell-based therapeutics that target age-related perturbations to rejuvenate the immune
response in periodontal disease. Further single cell analysis and bioinformatics techniques will produce
transcriptomic datasets to identify gene expression signatures associated with aging and inflammatory
dysregulation. Findings from this project will improve our understanding of immune regulation in bone, introduce
novel targets for therapy, and provide Dr. Clark with a novel independent research program.

Public health relevance
Project Narrative Proper regulation of inflammation within bone is critical for preventing disease and healing from injury. A dysregulated immune response becomes more prevalent in elderly populations and results in a susceptibility to numerous conditions, including periodontal disease. The goal of this project is to understand the age-related perturbations that occur to the cellular and molecular regulators of the innate immune response in bone.